MyTrials: An Integrated Tool to Support Remote Biomarker Capture within Decentralized Clinical Trials for Substance Use Disorders

PROJECT SUMMARY/ABSTRACT
Decentralized clinical trials (DCTs) for substance use disorders (SUDs) face a significant methodological
limitation: the need for biomarker collection. Though multiple approaches for remote SUD-relevant biomarker
capture exist, translational research barriers limit the utility of these approaches for SUD DCTs. First, existing
biomarker capture solutions have been developed primarily for clinical, not research, utilization. Thus, there are
research and commercial needs to integrate remote biomarker capture with existing data infrastructure. Second,
capture of each biospecimen typically functions independently, making collection of multiple biospecimens in any
one trial burdensome. This problem is particularly relevant for SUD research as half of individuals who use
substances use more than one, typically necessitating separate biomarker collection for each substance used.
There is clear need for a product that can facilitate collection of multiple biomarkers in any one SUD DCT. To
have maximum appeal, a product that will fill this gap must be able to be integrated in multiple trials across
institutions. Our team is at the forefront of innovating DCT methods, with our research shared in prominent outlets
such as JAMA. As part of our work, we recently completed prototype development of an integrated remote
biomarker capture system (called “MyTrials”) for DCTs. Development of the MyTrials prototype was funded by a
Phase I STTR from NCATS, and the product leverages REDCap, an online research data capture system with
2.9 million users that is freely available to research institutions. This prototype was not developed for SUD
research and does not facilitate capture of substance use-specific biomarkers. Thus, while our foundational work
supports technical feasibility, additional product refinements are needed to maximize applicability to SUD DCTs.
Within this fast-track STTR, we will develop, refine, and evaluate a customized version of MyTrials to support
the unique needs of SUD DCTs. During Phase I, MountainPass Technology LLC and MUSC will partner to
develop MyTrials consistent with established needs of SUD DCTs and feedback gathered during focus groups
with end-users and customers. Product development will build upon our MyTrials prototype with iterative
refinements completed in response to usability testing with end-users. During Phase II, we will conduct a
decentralized trial to evaluate the feasibility and acceptability of MyTrials among individuals who use substances.
Study participants (N=450) will be enrolled remotely and asked to use MyTrials weekly for 12 weeks.
Configuration of MyTrials will be matched to the participant’s current substance use. Main outcomes include: 1)
assessment completion rates, 2) percent of valid biospecimens submitted, 3) product usability, and 4) feasibility
and acceptability. Research activities are coupled with a strong commercialization plan which together will propel
our company toward Phase III and will address the pressing need for research tools to support SUD DCTs.

Public health relevance
PROJECT NARRATIVE Decentralized clinical trials (DCTs) for substance use disorders (SUDs) face a significant methodological limitation: the need for collection of biomarkers, which often serve as key trial outcomes. To address this need, the overarching goal of this fast-track STTR is to develop, refine, evaluate, and advance toward commercialization an integrated software solution that will facilitate feasible, rigorous remote biomarker capture within SUD DCTs. Phase I and II research activities are coupled with strong commercialization opportunities that will propel our company toward Phase III and beyond to support and improve DCTs for SUDs.